Impacts of universal influenza mRNA vaccine on enhancing the efficacy of seasonal vaccination

SUMMARY
Current influenza (flu) vaccines based on immunity to variable hemagglutinin (HA) provide low efficacy
because of continuing HA antigenic changes and poor cross-protection. The flu ion channel M2 protein
ectodomain (M2e) represents highly conserved epitopes and the HA-stem (HA2-fusion) is also an immune
target for conferring protection against different viruses. My mentor’s lab reported that heterologous (human,
swine, avian) tandem repeat M2e protein (5xM2e) could be a cross-protective immunogen and chimeric
M2e-stem protein vaccine conferred broad cross-group protection. Nonetheless, the prior 5xM2e and M2e-
stem protein vaccines require high doses and need to add neutralizing immunity. COVID-19 mRNA vaccines
have been approved to widely immunize six-month-old children to the elderly, validating mRNA vaccine
modality. My preliminary mouse study demonstrated that 5xM2e mRNA and M2e-stem mRNA vaccines
(encapsulated into lipid nanoparticles, LNP) effectively induced M2e and stem IgG antibody responses at a
low dose. Most innovatively, I found that 5xM2e mRNA-LNP supplemented conventional inactivated split
flu vaccination significantly enhanced the immunogenicity and efficacy with a single dose, probably
via transient induction of innate cytokine and chemokines. These preliminary data warrant further
investigation of this novel vaccination strategy of combining cross-protective flu mRNA and conventional flu
vaccines, overcoming a weakness of each vaccine platform. As supported by my preliminary data, I
hypothesize that neutralizing HA immunity (HA mRNA or split) plus universal target immunity (M2e-Stem
mRNA or protein) will offer increased immunogenicity leading to enhanced protection against homologous and
heterologous viruses. In aim 1, I will determine the immunogenicity and efficacy of protection against
homologous and antigenically different flu viruses after HA-based (HA mRNA or split) plus cross-protective
antigen (M2e-stem mRNA or protein) vaccination. For aim 2 approaches, I will investigate the immune
mechanisms of mRNA-LNP supplemented split- and protein-based vaccines inducing enhanced
protection. The potential mechanisms to study will determine the contribution of antigen-specific humoral
and cellular immunity to cross-protection, and the innate immune responses (innate cell phenotypes,
cytokines, chemokines), likely leading to enhanced adaptive immunogenicity of vaccines. The roles of Fc
receptor (FcR), natural killer (NK) cells, and ADCC (antibody-dependent cell-mediated cytotoxicity) in
conferring cross-protection will be determined by using mutant mice and in vitro assays. The expected
outcome of this project will advance our knowledge of how mRNA-LNP supplemented conventional vaccine
elicits enhanced efficacy. If successful, this project could open a new avenue for research in enhancing
vaccine efficacy for other pathogens.

Public health relevance
PROJECT NARRATIVE With the low efficacy of current seasonal influenza vaccines, it is highly significant to develop a high-performing, broadly cross-protective influenza vaccine to better protect public health. This project aims to investigate a novel approach combining cross-protective seasonal mRNA and conserved protein or split influenza vaccines to generate high immunogenicity and protection against circulating and pandemic potential viruses and to study the underlying immune mechanisms for enhanced efficacy.